Conference for Food Protection 2025 Biennial Meeting Support

Conference for Food Protection
Project Summary/Abstract
PAR-23-072
October 2024
The Conference for Food Protection (CFP), established in 1971, promotes food safety through collaboration
between regulatory bodies, industry professionals, academia, and consumer advocates. CFP works closely with
federal agencies like the FDA and USDA to address emerging food safety issues, including foodborne illness
outbreaks and evolving food technologies. Through its biennial meetings, CFP assembles three Councils—
focused on laws and regulations, administration and certification, and science and technology—composed of
experts from different sectors. These Councils deliberate on approximately 100 submitted food safety issues,
generating recommendations for the FDA Model Food Code and related regulatory practices. The Executive
Director then forwards these recommendations to the FDA for further action. In 2023, the CFP’s three Councils
reviewed 117 issues, 91 of which were adopted by the Assembly of State Delegates, demonstrating the impact
of the organization’s collaborative efforts. The CFP ensures equitable participation by offering travel subsidies
and involving diverse stakeholders in the planning, execution, and deliberation processes. The next biennial
meeting will take place in March 2025 in Denver, CO, with anticipated participation from 500 attendees. The
conference plays a crucial role in fostering regulatory uniformity across U.S. states and aligning food safety
practices with scientific advancements. Additionally, a virtual workshop is offered alongside the main
conference to provide supplemental, focused discussions on key food safety topics. Overall, the CFP facilitates
a unified approach to food safety, enhancing public health protections across the food supply chain.
1

Public health relevance
Conference for Food Protection Project Narrative PAR-23-072 October 2024 The Conference for Food Protection (CFP) is a nonprofit organization that fosters collaboration between regulatory agencies, industry, academia, and consumers to improve food safety standards, especially in areas related to food production and distribution. The CFP’s biennial meeting reviews food safety issues, formulates recommendations for the FDA Model Food Code, and facilitates dialogue among diverse stakeholders. These efforts help standardize food safety practices nationwide and ensure consistency across various jurisdictions. 1